Multi-level Influences of Violence Screening in College Health Centers

Abstract
Intimate partner violence (IPV) and sexual violence (SV) are significant public health issues for women,
particularly female college students. Twenty percent of women are sexually assaulted in their lifetime and
1.3 to 5 million women experience IPV each year. Female college students experience some of the
highest rates of IPV/SV of all groups, including older women and same age women who are not on
college campuses. IPV/SV can result in immediate and long-term adverse physical and psychological
health effects. Seven “Healthy People 2020” objectives focus on reducing IPV/SV. The National
Academy of Medicine and other national organizations recommend that health care providers (HCPs)
screen and counsel all women for current and past IPV/SV. College health centers represent unique
opportunities to screen college women and mitigate their risk for further violence and adverse sequelae.
However, college health centers have some of the lowest IPV/SV screening rates (10-20%) of all health
care settings. Studies demonstrate that scientific evidence does not translate consistently or rapidly into
clinical practice, particularly when recommendations go beyond what has been considered usual
practice. In order to promote the uptake of routine IPV/SV screening in college health centers, it is vitally
important to undertake formative implementation research to identify individual-, organization-, and state-
level factors that act as facilitators and barriers of screening. The proposed study will use an explanatory
sequential mixed-methods (QUAN+qual) design, framed within an organizational expansion of the
Theory of Planned Behavior (TPB) and the Consolidated Framework for Implementation Research
(CFIR), to collect and quantitative and qualitative data from a national sample of college HCPs and
female college students. The specific aims are to: (1) (Quant) Explore multivariate associations between
individual-, organization-, and state-level variables and college HCPs’ IPV/SV screening intentions and
rates, using disaggregated data; (2) (Quant) Examine fixed effects and random effects of individual-,
organization-, and state-level variables on college HCPs’ IPV/SV screening rates, using multi-level
modeling; (3) (Qual) Obtain in-depth understanding of college HCPs’ beliefs, organizational perceptions,
experiences with IPV/SV screening and practice change preferences; and (4) (Qual and Quan) Examine
female college students’ attitudes/beliefs and experiences related to IPV/SV screening and disclosure,
and compare to HCPs’ perceptions. The study findings will have high impact by elucidating how to
effectively implement IPV/SV screening recommendations and informing the development of a multi-level
intervention to promote screening in college health centers. Implementing routine IPV/SV screening in
college health centers can capitalize on missed opportunities for early detection, referral and
amelioration of the short- and long-term sequelae of violence.

Public health relevance
PROJECT NARRATIVE Intimate partner violence (IPV) and sexual violence (SV) are significant public health threats in the U.S. that result in short-term and long-term adverse outcomes. College women experience some of the highest rates of IPV and SV of all groups, including men, older women and same- age peers who are not attending college. Study findings will elucidate how to effectively implement IPV/SV screening recommendations from the National Academy of Medicine, and inform the development of a theory-based, multi-level intervention to promote violence screening in college health centers.